Glucose Optimization Through Technology Assisted Management (GO TEAM!):Use of a diabetes dashboard and community health worker to decrease disparities in technology use in pediatric T1D

Project Summary/Abstract
Disparities in glycemic control and diabetes technology use are now widely recognized at all socioeconomic
levels in Non-Hispanic Black (NHB) patients with type 1 diabetes (T1D). Recent data shows that NHB children
are less likely to start and less likely to continue use of a continuous glucose monitor (CGM), and are also less
likely to use an insulin pump. Automated insulin delivery (AID) systems, which require both CGM and insulin
pump, show greatest HbA1c improvement in those with baseline HbA1c over 8%, leading to concern that low
use of AID in NHB patients will further exacerbate existing health-care disparities. Therefore, novel interventions
to reduce disparities in technology use among NHB patients with T1D are critical to improving glycemic control,
reducing microvascular complications and preventing early mortality in NHB patients.
We aim to reduce disparities with a 2-part intervention: a diabetes triage dashboard with interactive smartphone
application and a community health worker (CHW) in the role of diabetes technology coach. A diverse advisory
group of stakeholders will define metrics of triage zones for the dashboard and frequency/content of messages
from the application and will refine the specific role of the CHW, Our shared goals are to 1) identify patients who
struggle to initiate or continue their device or do not meet glycemic goals and 2) utilize a CHW from the same
racial background and community to act as a diabetes and technology coach, building trust with families so as
to identify and overcome barriers to successful technology use.
The specific aims are to: 1) Convene a diverse advisory group of stakeholders to develop a protocol for a
diabetes dashboard and smartphone application; 2) Develop a diabetes dashboard and interactive application
using remote data capture from the cloud from CGM, insulin pumps, and AID systems; 3) Assess effectiveness
and implementation of the bundled intervention with a 1:1 randomized controlled study of NHB children and
young adults with new onset and insulin pump naïve existing T1D; 4) Aim 4: Understand lived experience of
diabetes management in context with 1:1 interviews, considering both perceptions regarding the intervention
itself (vs. usual care) and organizational/secular characteristics influencing that experience.

Public health relevance
PROJECT NARRATIVE: Diabetes technology is advancing at a rapid pace, but large disparities in the use of continuous glucose monitors, insulin pumps, and automated insulin delivery systems exist for Non-Hispanic Black patients with type 1 diabetes. There are many barriers to technology use in minority patients, and culturally-sensitive, effective solutions are needed. Based on feedback from patients and families with lived experience as minorities with diabetes, we will develop and evaluate an intervention utilizing 1) remote monitoring of technology use with diabetes management assistance and 2) personal support by a community health worker who will serve as diabetes technology coach to address barriers to sustained technology use.